SWOG 9343--ANDROGEN SUPPRESSION &FIXED SCHEDULE SURAMINE IN PROSTATE CA

In this study the primary objective is to assess the feasibility of fixed schedule suramine plus combined androgen suppression (orchiectomy plus flutamide, or LHRH agonist plus flutamide) in a cooperative group setting in patients with newly diagnosed Stage D2 prostate cancer. Feasibility evaluation is based on an assessment of the magnitude of suramine-related neurotoxicity or treatment interruption of four weeks or more. Also, progression-free survival and survival will also be estimated.